Resilience in Action: Building Resilience and Appropriate Independence in Young Adults with Autism

PROJECT ABSTRACT As young adults with autism spectrum disorder (YAASD) transition out of the academic supports provided by school, these young adults experience a degradation of social skills over time. This has led to poor academic, educational and health outcomes. YAASD require continuous and ongoing skill development in order to maximize their potential; however, there are few services available to adults with autism to develop and maintain their skills. While interventions exist in early childhood, mid-childhood and adolescence, few programs have been focused on the young adult with autism. Resilience in Action (RiA), is a research study, performed and delivered in the community setting, which seeks to develop supports to address the `adult world' needs of young adults with autism exiting out of secondary education. We propose to develop this program through three specific aims. In our first aim, we propose in-depth interviews with adults with autism and/or their families and service providers to better understand barriers and facilitators to “adult living” after graduating out of the school system. In our second aim, we will use the information gained from Aim 1 to develop a 12-week curriculum integrating a resilience framework and methodologies into a community adult life skills program for persons with disabilities,. A trained transition curriculum expert who had developed transition curriculum for youth with autism spectrum disorder in our local school district will assist in this “adult” curriculum to fill gaps that exist in the school district curriculum. As part of the infrastructure and support for this pilot, we will generate a protocol for the participant's existing case manager to help support youth and families after the curriculum is completed. Our third aim is to then pilot test RiA on 30 young adults with autism who have recently graduated from the secondary education system. Through an iterative program evaluation, we will further hone the intervention and adapt the program to different levels of disability and learning styles. We will measure characteristics of those who were successfully engaged in the program and measure outcomes such as socialization, quality of life, vocational/social activities and self-efficacy. Through this research we will have developed a final protocol for a resiliency course to be tested in a larger clinical trial to see how this type of curriculum can improve longer term social and health outcomes.

Public health relevance
PROJECT NARRATIVE Young adults with autism spectrum disorder face many challenges after they exit the school system which leads to poor social, vocational and health outcomes. This proposal, “Resilience in Action: Building Resilience and Appropriate Independence in Young Adults with Autism”, develops and pilots a resilience framework in a life skills program to assist and support young adults with autism spectrum disorder after they exit the school system.